Elucidating Social Determinants and Mental Health Needs to Achieve Equity in Rheumatic Disease Care

PROJECT SUMMARY/ABSTRACT
The rheumatic diseases systemic lupus erythematosus, rheumatoid arthritis, and osteoarthritis together
affect up to one-quarter of the U.S. population, with huge physical, social, psychological and financial
burdens. Profound disparities in care and outcomes are seen among those afflicted with these diseases,
with women and historically marginalized populations disproportionally impacted. Social determinants of
health (SDoH) including social risk factors such as food insecurity and financial strain, as well as potential
buffers of these risks such as social support, are not routinely assessed as part of rheumatology care yet
directly impact the health of individuals with rheumatic diseases and likely exacerbate disparities. Those
suffering with these rheumatic diseases are much more likely to have mental health conditions, notably
major depression and post-traumatic stress disorder (PTSD), and emerging research points to shared
genetic predisposition to mental health disorders and autoimmune rheumatic diseases. Many individuals
with rheumatic diseases do not receive timely, high-quality care or adequate preventive healthcare
resulting in increased emergency department visits and hospitalizations for oftentimes avoidable
outcomes including vaccine-preventable infections and major cardiovascular events. Leveraging All of
Us data from a large and diverse U.S. population, we propose novel studies to address modifiable barriers
to healthcare access and outcomes for patients with rheumatic diseases, a unique at-risk group due to
the physical and financial burdens of these diseases and the historically marginalized populations most
affected. To date, the influence of SDoH and mental health conditions, and potential buffering factors that
could be optimized, have been poorly examined and little addressed. We will investigate these crucial
questions within All of Us with >50,000 individuals with rheumatic diseases with linked electronic health
records, surveys regarding SDoH, demographics, healthcare access, and genotyping data. Among
individuals with rheumatic disease, we will 1) use a social risk factor index to assess the effects of SDoH
on recurrent, avoidable acute care use and 2) examine the impact of depression and PTSD on avoidable
hospitalizations and cardiovascular events, accounting for social factors. We will employ validated
polygenic risk scores for depression and PTSD to understand differences in genetic risk among
individuals with rheumatic diseases and assess effects of high genetic risk on acute care use as possible
markers for undiagnosed, untreated disease. Our findings, understanding the interplay of these
understudied factors, will allow interventions to begin to achieve equitable care and outcomes for those
most affected by the rheumatic diseases.

Public health relevance
PROJECT NARRATIVE The rheumatic diseases systemic lupus erythematosus, rheumatoid arthritis, and osteoarthritis together affect up to one-quarter of the U.S. population, with huge physical, social, psychological and financial burdens, with women, people who are non-White and of lower socioeconomic status most affected. We will use rich All of Us data from a large and diverse U.S. population to study barriers to healthcare access and outcomes for patients with rheumatic diseases. We will use detailed electronic health record, survey, and genotyping data, to test strong hypotheses about under-recognition of mental health problems and social determinants of health that lead to high rates of potentially avoidable emergency department visits and hospitalizations to help target strategies to reduce disparities in preventable outcomes for patients with rheumatic diseases.